Children's Hospital Los Angeles Site Consortium - Adolescent Medicine Trials Network for HIV/AIDS Interventions (ATN) Operations and Collaborations Center (UM2 Clinical Trial Optional)

ABSTRACT Children's Hospital Los Angeles (CHLA)
Children's Hospital Los Angeles (CHLA) is proposing to be the lead site for the Los Angeles Consortium. The
primary aim is to collaborate with Westat as the Adolescent Trials Network (ATN) Operations and
Collaborations Center (OCC) to successfully plan and implement ATN clinical research studies to meet the
priority areas as outlined in SLC RFA-HD-23-020. CHLA will leverage the strength of the Connect to Protect
Los Angeles (C2PLA) Coalition to lead a Research Advisory Committee of community, clinical, and academic
partners to:
1. Conduct the Research Projects identified by the ATN Executive and Scientific Leadership Committees;
2. Participate in the development of trials using our community, academic, and clinical partners in
conjunction with the ATN Scientific Core to meet the needs of adolescents and young adults (AYA) at-
risk for or living with HIV;
3. Contribute to innovative strategies within ATN V regarding successful recruitment and enrollment of
participants through established collaborations among clinics, academic universities, community-based
organizations, health departments, and other partners;
4. Provide sites with local laboratory capacity and pharmacy support; and
5. Establish a leadership model with meaningful and sustained community engagement efforts to ensure
that research studies reflect where AYA are accessing prevention and care services.
Our proposed consortium will initially include nine partners who will bring their strength and diversity to a site
consortium that will include clinical, academic, government, community, and other partnerships. We have four
clinical sites that provide care to AYA living with HIV and at risk for HIV including mostly LGBTQ AYA of color
and two partners that currently house large databases of AYA living with HIV and at risk for HIV: ATN CARES
at UCLA and the NIDA UO1-funded Healthy Young Men/A Trans Youth of Color Study cohort at CHLA. We
have initially targeted four community-based organizations and the County of Los Angeles Department of
Public Health Division of HIV and STD Programs. Representatives of these groups and our AYA community
advisory boards will form an innovative leadership structure that is representative of our communities and can
provide leadership through protocol review, new protocol development, and guidance on recruitment and
retention. Based on decades of experience with clinical services and research with AYA, our proposed Los
Angeles ATN V Consortium is well suited to join the OCC and other city consortia. CHLA has exceptional
access to AYA likely needed in future clinical trials, decades of ongoing community partnerships, and an
outstanding track record for recruiting and retaining hard to reach AYA into clinical trials, including complex
medical interventions requiring investigational new drugs (IND), research laboratories, and pharmacy services.